Structural Studies of Macromolecular Assemblies Using Cryo-EM

Project Summary/Abstract
The main objective of the proposed studies is the elucidation of fundamental processes of translation,
translational regulation and translational quality control. To this end, single-particle cryo-electron microscopy,
the technique pioneered in the PI's lab, is used in collaborations with world specialists on bacterial and
eukaryotic translation. We make use of two techniques of sample preparation, standard and time-resolved
cryo-EM. In the standard application of cryo-EM, samples are pipetted onto the grid, excess liquid is removed
by blotting, and the grid is then plunged into the cryogen. Since this procedure requires several seconds, it is
not possible to capture short-lived (less than 1000 millisecond) states of a molecule following a reaction. The
alternative technique developed in this lab is time-resolved cryo-EM, whereby a reaction is started by mixing
two components in a microfluidic chip, allowing them to react in a channel of defined, variable length (10 to
1000 ms), and then spraying the reaction products onto the grid as the latter in plunged into the cryogen. In
this way, the kinetics of a reaction can be followed and, at the same time, intermediate states can be captured
and visualized at high resolution. These two techniques are used to study the following processes: translation
initiation in E. coli and yeast, translation termination, recycling and quality control in mammalian, EMCV virus
takeover of the host's ribosome. Another objective of the proposed studies is the exploration of a novel method
of data analysis that seeks to generate a low-dimensional map of states existing in a continuum from a large
dataset of single-particle cryo-EM images of a biological macromolecule. Such a mapping can be used to
determine the free-energy landscape of the molecule, containing information on the function-related
conformational trajectories. This method will be applied in collaborations with leading experts to two
membrane-associated molecules with eminent biological and public health significance: rotary ATPase and
Cystic Fibrosis trans-membrane conductance regulator (CFTR).

Public health relevance
Project Narrative Single-particle cryo-EM, a method of molecular structure research pioneered in the PI's lab, has been further developed with the inclusion of time-resolved techniques to allow capture and structure determination of short- lived states. A combination of standard and time-resolved techniques will be applied to elucidate processes in protein biosynthesis with fundamental significance to public health. In addition, a novel method of data analysis aiming at characterization of the dynamic behavior of molecules will be applied to large datasets of important membrane-associated molecules: rotary ATPase and Cystic fibrosis trans-membrane conductance regulator.